Multidisciplinary Rheumatology Training Program

Project Summary
The long-term objective of the T32 Multidisciplinary Rheumatology Training Program (MRTP) at Johns Hopkins
University is to train and develop a cadre of outstanding rheumatologists and scientists who will
advance knowledge and improve outcomes for people living with rheumatic disease, and who will
become leaders across the biomedical research enterprise. This goal is directly relevant to the NIAMS
mission to support the training of investigators conducting research into the causes, treatment, and prevention
of arthritis and musculoskeletal diseases.
This will be accomplished through the following Specific Aims: (1) Provide rigorous instruction in
investigational methods to postdoctoral fellows, applicable to the conduct of clinical, translational, and basic
research; (2) Utilize clinical centers of excellence to access well-defined rheumatic disease patient
populations, enabling trainee projects to be rapidly initiated on established patient cohorts; (3) Provide access
to outstanding resources and methodologic and analytic expertise that facilitate research success; (4)
Engage trainees in high caliber collaborative research projects that address important questions and test
meaningful hypotheses under the supervision of nationally-renowned multi-disciplinary program faculty; (5)
Integrate multi-layered and individualized mentorship for each trainee to develop meaningful scholarship
and a successful investigative career; (6) Assess the outcomes of this program and make modifications to
maximize its success.
In this proposal, we demonstrate the outstanding clinical and translational infrastructure we have developed to
support training and research. This infrastructure includes highly productive program faculty and mentors,
vibrant interdepartmental collaborations and multidisciplinary investigative teams, a robust institutional
commitment to postdoctoral training in rheumatology at Johns Hopkins, and a robust pool of trainee
candidates.
The core of the experience is the close relationship between a primary mentor, co-mentors, and the trainee
around specific research projects. This is supplemented by individual development plans, formal course work,
and core conferences. Our trainees’ education includes training in the responsible research conduct, career
planning, grant writing, and manuscript preparation. Postdoctoral trainees in the clinical sciences can also earn
a Masters in Health Sciences Degree.
This program combines intensive training in a single area of investigation within a matrix of multidisciplinary
collaborations. Only post-doctoral fellows are eligible for the T32 MRTP, which will support 4 post-doctoral
trainees annually, each for a period of 1-3 years. A wide range of training opportunities will be provided by a
large interactive network of faculty supported by individual, collaborative, and inter-institutional research grants.

Public health relevance
Project Narrative There is a growing need for well-trained investigators in rheumatic diseases, to define pathophysiologic mechanisms, recognize phenotype and trajectory, identify risk factors, and direct intervention and prevention programs. The goal of this program is to train highly qualified individuals to be future leaders in rheumatology.